Core A: Administrative Core

ABSTRACT (Core A)
The Administrative Core (Core A) will provide support and effort coordination for each of the
projects in this P01, as well as the three scientific cores. The aims of the Administrative Core are
to ensure that the resources within the P01 are distributed equitably to the investigators and that
all rules and regulations of the National Cancer Institute and the National Institutes of Health are
followed. The Administrative Core will coordinate meetings of the investigators and their
laboratories and facilitate communication between our investigators with the External and
Internal Advisory Boards. The finances of the P01 will be organized by Ms. Jenine Iannaccone,
Grants Administrator in the Department of Radiation Oncology, who will meet monthly with the
P01 Principal Investigator and quarterly with each Project and Core Leader. Ms. Andrea Rycroft,
Administrative Coordinator, will coordinate travel arrangements for the members of the P01, as
well as the advisors who will visit the University of Pennsylvania. She will also provide
administrative support for each of the P01 investigators for efforts related to the Program. It is
anticipated that through the combined efforts of the Core Directors, Ms. Rycroft and Ms.
Iannaccone, the research operations and communications of the P01 will run with optimum
efficiency.

Public health relevance
NARRATIVE (Core A) The overall goal of this Core is to provide organizational support and oversight of the scientific and budgetary component to the overall Program Project. This will ensure the timely performance of the proposed work and evaluation of its results. The Administrative Core will also play an essential as an interface with the NIH/NCI.